Integrated Regional Training Program in Environmental Health Sciences

PROJECT SUMMARY/ ABSTRACT
The objective for our Integrated Regional Training Program in Environmental Health Sciences continues to be
to recruit and train scientists in the Environmental Health Sciences (EHS). Primary goals are: 1) Recruit a
diverse cohort of trainees; 2) Individualize transdisciplinary, experiential learning employing Individual
Development Plans (IDP) for each trainee to provide structured scientific, professional and career development
in the environmental health sciences; 3) Train the next generation of scientists to be leaders in environmental
health sciences (EHS). Renewal funding is requested to support 6 pre-doctoral trainees and 3 post-doctoral
trainees. We have a strong pool of pre-doctoral and post-doctoral applicants, who are evaluated and selected by
the Co-Directors and our Internal Advisory Committee. Our recruitment process is designed to attract the best
and brightest while also attaining diversity in our training cohort by attracting trainees from underrepresented
and disadvantaged groups in STEM. The outcome of our training program will be to matriculate trainees with
the skills, experience, and ethics to address a wide range of complex, critical, and rapidly evolving problems in
EHS. Our regional, transdisciplinary training program will extend our nearly 50 yr. tradition of excellence in
collaborative EHS research and training between Oregon State University (OSU), Oregon Health Sciences
University (OHSU) and Pacific Northwest National Labs (PNNL). The major evolutions of our training
program include: implementation of Individual Development Plans (IDPs) as the foundational framework for
our training program; reduction in didactic coursework; new mentors and research topics; and short
externships to further promote interdisciplinary training and professional development in real-world potential
employment environments. IDPs provide the framework for flexible, individualized professional development
and experiential training needs in the context of rapidly evolving and emerging challenges in EHS. Trainees
will acquire the core competencies to be successful throughout their careers. Major strengths of our program
continue to be our highly productive and collaborative training faculty; our existing highly successful
multidisciplinary training program; and the unique collaborative training environment provided by OSU,
OHSU and PNNL and supplemented by new regional training partners in the academic, regulatory, and private
sectors. Our evolving mentor cohort includes 30 continuing and new faculty mentors, offering a wide diversity
of training topics in EHS: molecular toxicology, environmental chemistry, ecotoxicology, systems toxicology,
hazard identification, exposure biology, epidemiology, developmental toxicology, nanotoxicology,
computational and predictive toxicology, microbiome/environment interactions, neuro/behavioral toxicology,
inter-individual susceptibility, metal toxicology, metabolism, diet-environment interactions and translational
data sciences. Our former trainees continue to make major contributions in the academic, public, and federal
sectors demonstrating the effectiveness of our training program.

Public health relevance
PROJECT NARRATIVE Our training program has an exemplary record of accomplishment for training the next generation of scientists for impactful careers in environmental health sciences and public health. Trainees completing our transdisciplinary program are employed in academic, regulatory, commercial, and non-profit sectors to address current and emerging NIEHS research priorities and solve complex, real-world environmental problems to improve human and environmental health.